Hepatic gene transfer for the treatment of hemophilia B and other genetic diseases

Adeno-associated viral vectors (rAAV) have shown promise in some liver-based clinical trials
including hemophilia B. However, one of the limitations is the loss of the vector genomes during
tissue growth and cell division limiting the duration of expression when treatment is initiated early
in life. For success in treating a number of genetic diseases treatment early in life is required. We
previously developed a non-nuclease mediated AAV-mediated homologous recombination (AAV-
HR) approach by using genomic homology arms to insert a protein coding sequence onto the end
of the endogenous Albumin gene such that after homologous recombination, the modified locus
would make a chimeric mRNA and both the endogenous albumin protein and a second protein,
in our case human factor IX and treated the bleeding diathesis in a murine model of hemophilia
B. Subsequently, this approach has been used to treat other murine models of human
hepatodeficiency disorders and a Phase I/II clinical trial for methylmalonic acidemia was initiated
by LogicBio therapeutics. The limitation is the efficiency of the process remains low and we have
recently established that off-target integration likely can produce a proportion of the therapeutic
protein. Our goal is to further study the genomic sources of the AAV-HR produced therapeutic
product as well as parameters that influence the efficiency of AAV-HR in cells and in vivo. To do
this, we will use high-throughput sequencing approaches to molecularly characterize the origin of
off-target transcribed RNAs produced after AAV-HR mediated transduction. We will establish if
they arise from vectors that integrate into regions of microhomologies or via non-homologous end
joining as well as identify which sets of these RNAs are translated. Our preliminary data suggests
that regions of the host genome that are more robust in R-loop formation will likely be more
efficient at AAV-HR. We will directly test this hypothesis and use the information to design
improved homology arms for AAV-HR. We will also do an unbiased in vivo genetic screen in mice
to establish which genes when expression is reduced results in higher AAV-HR. We will confirm
that parameters that influence non-nuclease mediated AAV-HR also effects nuclease mediated
AAV-HR. The results from these studies will not only provide new mechanistic insights into AAV-
HR but provide new approaches for enhanced genome editing, which would broaden the
application for treating human genetic diseases.

Public health relevance
The goal of this work is to improve our knowledge and increase the efficiency of adeno- associated viral vectors for genome editing approaches. This will improve current genome editing/therapy approaches, which may provide lifelong treatment for patients suffering from genetic diseases.